The effects of hydrocodone rescheduling on pain management of older lung cancer patients

Project Summary
Pain is a highly prevalent, complex, debilitating symptom for cancer patients. Pain
management is an essential component of cancer care. Adequate pain management can
significantly improve health-related quality of life for patients. However, there are substantial
disparities in access to adequate pain management especially among underserved and
underprivileged populations. Meanwhile, the opioid epidemic is a serious public health crisis,
and there have been many policy efforts to curb opioid misuse. One important policy change is
the rescheduling of hydrocodone from Schedule III to Schedule II in 2014 by the United States
Drug Enforcement Administration. However, prior literature has shown mixed evidence on the
actual overall impacts of this policy, as patients could either receive non-opioid
pharmacotherapy (e.g. nonsteroidal anti-inflammatory drugs, antidepressants, muscle relaxant,
anticonvulsants) or stronger opioids as replacements for hydrocodone. Additionally, few
studies examined the impact on pain management strategies and outcomes among cancer
patients, who may face potentially higher barriers to adequate pain management. Further, how
the policy change affects underserved and underprivileged groups is largely unknown.
We propose to use national cancer registry data linked with Medicare claims (SEER-
Medicare) to comprehensively examine the effects of the rescheduling of hydrocodone on older
lung cancer patients with a special focus on underserved and underprivileged groups. The
proposed study is well in line with the R21 RFA calling for research that utilizes Centers for
Medicare and Medicaid Services (CMS) administrative data to study pain management
strategies and outcomes, including underserved and underprivileged groups.
We will address the following aims: Aim 1. Examine the change in opioid and non-
opioid pharmacotherapy use among older lung cancer patients before and after the
rescheduling of hydrocodone from Schedule III to Schedule II. Aim 2. Compare the adequacy of
pain management in terms of prevalence of service use consistent with inadequate pain
management among older lung cancer patients before and after the rescheduling. Aim 3.
Examine potential disparities in the use of medications for pain management and service use
consistent with inadequate pain management among older lung cancer patients dually eligible
for both Medicare and Medicaid and among patients in racial/ethnic minority groups.
The proposed study will provide important insights to guide policy efforts and clinical
practice aimed at improving pain management and reducing disparities in cancer patients.

Public health relevance
Project Narrative Pain management is an essential component of cancer care; however, there are substantial disparities in access to adequate pain management especially among underserved and underprivileged populations. In response to the opioid epidemic, the United States Drug Enforcement Administration rescheduled hydrocodone from Schedule III to Schedule II in an effort to reduce opioid misuse. Given the lack of evidence on its impact on pain management of cancer patients especially the underserved and underprivileged groups, this study aims to gain a better understanding of the complex relationship between policy, patients, and providers in terms of pain management strategies, outcomes, and disparities among older lung cancer patients.